The Potato Project-Implementing food safety strategies in retail food establishments in order to reduce the incidence of risk factor violations through training, materials, and communication.

The Potato Project Food safety is an issue across the state of North Carolina, as well as the entire country. At the local level of government, environmental health departments are usually tasked with performing routine food safety inspections to retail establishments. In order to make the best use of time and complete a quality, science-based inspection, local level inspectors require minimal tools to achieve and record temperatures of food products as well as a means of recording those temperatures and the findings of their inspection. They are further required to reproduce that information in an easy-to-understand report to the food establishment and make the report available for viewing by the general public. By utilizing key software, this information can be easily recorded and formatted to quickly achieve a standardized report that details findings of the inspection, recorded temperatures, and intervention strategies to reduce the incidence of risk factor violations in retail food establishments. It is equally important that materials relating to the bigger issues found in retail food establishments be available for dissemination by inspectors while in the field. Basic, easy-to-read, informational materials like magnets, stickers, and cards can be easily distributed by inspectors, with the hope that food employees will remember some vital details during their time at work. By obtaining this software and these materials, our inspectors will be able to more easily review previous inspections, run detailed reports that collect information about certain risk factor violations while simultaneously creating an on-going data baseline, and reduce the amount of time spent entering repetitive data; They will be able to quickly and easily provide basic, tangible information to the establishment which ultimately will assist us in achieving a 100% compliance of retail food establishment inspections per year. These achievements will provide training opportunities for our local food establishments through a higher frequency of inspections, as well as produce a safer, more informed, community.

Public health relevance
The Potato Project Narrative- A potato can be cooked or prepared thousands of different ways. The namesake of this project utilizes the idea that since potatoes are abundant, inexpensive, and universally prevalent in international cuisine that there is no better vegetable to use to promote food safety through in- house training in retail food establishments, as well as providing informational material during routine inspections and promoting awareness of additional resources about food safety. Our community outreach team can take a bag of potatoes into a retail food establishment, show that they are from an approved source, cook them to the correct final cook temperature, demonstrate several different methods of cooling, show correct methods for hot and cold holding, all while exhibiting good personal hygiene practices. We will employ Digital Health Department (DHD) computer software to compare previous inspections and use this information in conjunction with our quality assessment program in order to more closely meet standard number 4 and standard number 7 of the VNRFRPS. Additionally, we will use DHD to collect routine inspection information to identify specific risk factors most prevalent in our community to move toward meeting standard number 9. We have made connections with neighboring districts in our area and are willing to assist them in enrolling in and completing a self-assessment of the program standards.